Cofactor-Mediated DNA Binding by the NF-kappaB Dimers

Project Summary
The NF-­ κB dimers bind to specific DNA response elements known as the κB DNA sites located in the
promoters and enhancers of thousands of genes, and regulate their expression. Although the roughly 10 bp
long κB sequences follow a consensus, hundreds of specific sequences can fit the consensus. Sequence
variations can result in differences in NF-­κB-­DNA binding affinity, kinetics and conformations leading to
changes in transcriptional output. Indeed, other and we reported that as few as a single bp change can
have severe effect in gene regulation by the NF-­κB dimers. Affinities of the NF-­κB:DNA complexes derived
from in vitro experiments do not always correlate with in vivo binding and gene regulation. These
observations suggest that there are modulators present in the cell and without their inclusion in in vitro
experiments in vivo and in vitro results will not reconcile. On the other hand, without proper in vitro
experimental set up, proper investigation of regulatory mechanisms in vivo is difficult to accomplish.
Cellular experiments performed over the past 10 years established the presence of several of such
modulators, but their mechanisms of action could not be properly explained without thorough biochemical
and biophysical experiments. We term these modulators cofactors. These cofactors alter the DNA binding
affinity of NF-­κB p50:RelA heterodimer and RelA homodimers in a κB sequence-­specific manner. The
focus of this proposal is to use new experiments to propose a unifying principle of how the cofactors
regulate NF-­κB activity.
We propose that when the affinity between an NF-­κB:κB DNA complex is weak, a cofactor can act
positively enhancing the affinity of NF-­κB:DNA complexes by directly contacting NF-­κB without contacting
DNA allowing gene expression to occur. Alternatively, a cofactor can act negatively by removing NF-­κB off
the DNA (or reduce affinity). Several positive cofactors and few negative cofactors are known. We will
investigate the mode of actions of a few of these cofactors in vitro. Specifically, we will identify the site of
interaction of both positive and negative cofactors on RelA and how they use allosteric mechanism to alter
DNA binding by RelA. Since no cofactor specific to p50 is known, we also plan to identify cofactors specific
to the p50 subunit and investigate if and how these new cofactors act together with RelA-­specific cofactors.
We will generate mutants of RelA defective in cofactor binding and test how gene expression profile and
DNA binding in cells alters in response to specific stimulus.

Public health relevance
Project Narrative Transcription of eukaryotic genes is a highly complex process that requires communication between the promoter DNA and sequence- specific DNA binding transcription factors such as NF- kappaB (NF- κB) dimers. Our proposed research plans to uncover how cofactors regulate the DNA binding of NF- κB RelA dimers, and how in the absence of cofactors the recruitment of RelA in gene promoters is affected leading to defective biological programs. This proposal plans to identify NF- κB subunit- specific cofactors and investigate the detailed mechanism of cofactor- assisted DNA binding of NF- κB dimers.